Antibody-triggered mouse models of neuropsychiatric lupus: heterogeneity, mechanisms and therapeutic approaches

Abstract - Project 1: Antibody-triggered mouse models of neuropsychiatric lupus: heterogeneity,
mechanisms and therapeutic approaches
This project will continue to develop murine models of neuropsychiatric lupus (NPSLE) that phenocopy the
human disease and are initiated by penetration of anti-DNA, anti-N methyl D-aspartate antibodies (DNRAbs) into
brain parenchyma. We have previously developed and characterized a model with hippocampal injury and
memory dysfunction. We propose to characterize a model with injury in the amygdala and anxiety and will try to
develop a model with depression and fatigue. In all models, we will characterize glial neuronal interactions. We
will determine if agonism of the aryl hydrocarbon receptor is a therapeutic strategy for brain inflammation or if,
in fact, it exacerbates the inflammatory process. We will determine whether, and how, type 1 interferon
contributes to brain pathology. Finally, we will utilize a microglia-neuron co-culture system to understand the
contribution of particular pathways to the in vivo pathology. These studies interdigitate with our studies of
patients, Both projects are designed to understand disease heterogeneity and the cellular and molecular basis
for major manifestations of disease, cognitive impairment, anxiety, depression and fatigue, and to develop
therapeutic strategies that take heterogeneity of pathogenetic mechanism into account.